Core A - Administrative

PROJECT ABSTRACT
The primary function of the Administrative Core within The Massachusetts General Hospital Harvard Center for
Reproductive Medicine will be to provide an organizational platform that will seamlessly integrate the Center's
scientific, regulatory, human resource, and financial interfaces across the two individual research Projects, two
supporting Cores and collaborating institutions. These functions will be achieved through three aims. Aim 1 is to
support the primary scientific goal of the P50 in elucidating the genetic and phenomic architecture of rare and
common infertility traits. To achieve this aim, the Core will provide administrative support to: (a) facilitate patient
recruitment for phenotyping protocols; (b) coordinate scientific meetings to enhance efficiency and productivity
of individual Projects & Cores; (c) coordinate space management; (d) facilitate scientific reporting and, (e) ensure
proper regulatory compliance. Aim 2 is to 'un-burden" P50 investigators, by providing infrastructure and timely
support to catalyze a collaborative think-tank comprised of Center personnel from across the globe. To achieve
this aim, the Core will provide administrative support to: (a) coordinate and disseminate meeting
agendas/materials to participants; (b) coordinate travel arrangements for investigators, fellows and staff within
the two scientific projects and supporting cores; (c) oversee optimal functioning of information technology (IT)
services; and, (d) facilitate post-award grant management. Aim 3 is to serve as a “nuclear hub" for engagement
and communication between P50 investigators, the patients they serve, mentees and the broader academic
community. To achieve this objective, the Core will provide administrative support to: (a) Education/Outreach
Core patient meetings and focus groups; (b) orient new personnel and staff to the Center; (c) coordinate the
Visiting Professor series through the academic year; (d) coordinate a Harvard-wide Annual Symposium
celebrating reproductive medicine and biology across the Massachusetts General Hospital, Brigham & Women’s
hospital and Harvard Chan School of public health; and, (e) maintain a social media presence to disseminate
scientific findings, advertise research positions and publicize activities (i.e. patient meetings, Speaker Series,
Annual Symposium). The Administrative Core will provide end-to-end support for Projects 1 and 2 as well as
Technical Service and Education/Outreach cores to effectively carry out their planned activities. Coordinated
Administrative Core activities will amplify the Center’s productivity and dissemination of results that will in turn
benefit clinical care of patients with infertility and alleviate the physical and psychological burden of infertility for
patients and their families.